Using Vagal Nerve Stimulation in Conjunction with NRT for Smoking Cessation

PROJECT SUMMARY
This research proposal aims to evaluate vagal nerve stimulation (VNS) as a novel treatment for Tobacco Use
Disorder (TUD), targeting improved smoking cessation rates. Cigarette smoking remains a major public health
issue, leading to over 400,000 premature deaths annually in the U.S. and contributing to diseases such as lung
cancer, chronic obstructive pulmonary disease (COPD), and heart disease. Despite widespread awareness of
the risks and a strong desire to quit, many smokers are unsuccessful in their attempts, with only a small
percentage achieving long-term abstinence. Current FDA-approved treatments—nicotine replacement therapy
(NRT), varenicline, bupropion, and transcranial magnetic stimulation (TMS)—offer limited success in terms of
efficacy and accessibility. There is a clear need for more effective and accessible treatments to support
smoking cessation in TUD. This study's innovation lies in exploring VNS as a neuromodulation technique for
treating TUD. Preclinical studies suggest that the vagal nerve is involved in addiction pathways, making it a
promising target for smoking cessation interventions. This study will be the first to test VNS as a treatment for
TUD using a non-invasive, handheld, and portable device, addressing key barriers to existing therapies like
TMS, which requires specialized centers, and surgically implanted VNS devices. By using a pragmatic,
decentralized clinical trial (DCT) approach, the study will combine VNS with existing pharmacotherapies, such
as NRT and varenicline, to enhance smoking abstinence rates. The proposed phase-II randomized, double-
blind, parallel-group clinical trial will assess the efficacy of NRT plus active VNS versus NRT plus sham VNS in
smokers. Participants will receive 12 weeks of nicotine patch treatment combined with VNS, with an additional
12 weeks of varenicline and VNS for those who do not achieve abstinence. The trial will utilize remote carbon
monoxide (CO) monitoring and telehealth visits to create a fully decentralized clinical trial environment,
allowing for a patient-centered approach. Recruitment will occur through the Mayo Clinic’s Nicotine
Dependence Center, leveraging our extensive experience in smoking cessation research. The primary
endpoint of the study is biochemically confirmed smoking abstinence at 12 weeks, with secondary outcomes
including prolonged abstinence at 24 and 26 weeks. This trial aims to provide preliminary evidence for the
efficacy of combining VNS with NRT and varenicline, potentially leading to large-scale trials and FDA approval
of VNS as a viable treatment for TUD. If successful, this research could add a novel, effective, and accessible
therapy to the limited treatment options currently available for smokers attempting to quit.

Public health relevance
PROJECT NARRATIVE Tobacco abuse continues to be a leading cause of preventable death in the United States, but we may be able to address it with a vagal nerve stimulator (VNS) which has been approved for headache relief. The proposed study will evaluate 12 weeks of VNS as an adjunct to nicotine patches as well as retreatment of VNS as an adjunct to varenicline for those who persist in smoking after 12-week for long-term. If successful, may add VNS to the limited number of treatment options for patients with tobacco dependence.